Obtaining Samples from Human Subjects to Facilitate Basic, Translational and Clinical Research

This protocol defines in general terms the purposes for which blood, urine and ultrafiltrate will be collected from adult research subjects and healthy volunteers by members of the NIH Clinical Center's Critical Care Medicine Department and collaborating institutions and establishes general conditions under which sampling will be performed. Blood drawing will be consistent with NIH Clinical Center guidelines. The Critical Care Medicine Department and our associated investigators are involved in the development of new translational research protocols and maintenance of existing IRB approved research protocols. This protocol will support the establishment of new translational research protocols through assay development and provide information to guide the effective implementation of new protocols as well as maintain efficiency in operations of existing protocols. The protocol was approved by the National Heart and Lung Institutional Review Board in August 2017. As of August 2018 a total of 25 subjects have enrolled (5 healthy controls and 20 patients). 20 Research Subjects provided blood samples for DNA gene sequencing for Pulmonary Arterial Hypertension. 1 Healthy Control provided blood samples for immunophenotyping for relapsing polychondritis. 1 Healthy Control provided blood samples to isolate B cells for flow cytometry and samples for immunophenotyping for relapsing polychondritis. 3 Healthy Controls provided blood samples for Cell Free DNA isolation.